ROLE OF GLUCAGON IN INCREASED LEUCINE OXIDATION IN INSULIN DEPRIVED DM

The aim of this protocol is to determine whether the increase in leucine oxidation tha tis seen in insulin dependent type I diabetes is attributable to the hyperglucagonemia that occurs during insulin deficiency.